New Strategies in Catalytic Organic Synthesis with Organoboron Reagents

Project Summary.
New functional group transformations can enable synthetic chemists to disconnect
molecules in new ways, thereby enabling new synthesis strategies. Ideally such new
technologies enable the synthesis of important molecules from untapped, perhaps more
readily available, starting materials. The proposed research will extend our fruitful
studies on catalytic diboration, catalytic cross-coupling, and catalytic boronate
rearrangements to address important new stereoselective transformations. Our
strategies are keenly focused on developing processes that are readily accessible to the
end-user without specialized techniques, equipment, or materials.

Public health relevance
Project Narrative. Single-enantiomer chiral compounds are vitally important as new materials and as medicinally relevant therapies. The proposed research will develop new technologies for the construction of such compounds from simple, readily available natural resources.